Wisconsin Allergy Research Training (WiscART) Program

The Wisconsin Allergy Research Training (WiscART) program aims to provide research training for postdoctoral fellows in Allergy and Immunology to prepare trainees for careers as independent academic research scientists. Objectives to achieve this goal include helping trainees establish a high-quality and productive research project related to allergy/immunology and developing abilities in leadership and education. There are generally 4-6 Allergy/Immunology fellows in the UW program, and four fellows supported by the WiscART program. The post-doctoral trainees are PhDs or MDs who have completed Pediatrics or Internal Medicine residency training. For physicians, the School of Medicine and Public Health and the Departments of Medicine and Pediatrics leverage the T32 funds by providing funds for salary support and stipends for additional training years not covered by WiscART. The WiscART trainers include clinical, translational, and basic scientists, and there are exceptional opportunities for trainee research projects. Training by traditional scientific and career mentorship is supplemented by outstanding educational programs offered by the University of Wisconsin CTSA (Institute for Clinical and Translational Research), including optional advanced degree and certificate programs in clinical and translational research. The program has consistently recruited outstanding trainees with a variety of backgrounds and interests. Overall, 63% of our graduates have pursued academic or research-focused careers upon graduation from WiscART.

Public health relevance
It is critical to determine mechanisms for allergic and immune-mediated diseases, including asthma, to enable improved prevention and treatment for these common diseases. The goal of this program is to provide training in clinical and translational research to physicians and PhD scientists who wish to pursue academic careers devoted to research, education, and leadership in these critical areas of unmet medical need.